Dissemination and Outreach Core

Dissemination and Outreach Core Abstract Text
The TRANSFORM Center Renewal’s Dissemination and Outreach Core (DOC) is congruent with the Overall, Administrative and Resource Cores, and the team will work closely with the research projects to provide support and consultation relative to community outreach, legal and medical use data acquisition, and dissemination of final products using the Academy Health approach to reaching broad audiences. The DOC will engage scientific and lay professional communities to share 40 years of child abuse and neglect (CAN) research to raise awareness to a broad transdisciplinary audience. We have a four-year history with our first funding cycle where we are reaching all 50 states and 11 countries. We will build on our dissemination networks to enhance our reach. We prioritize first responders as well as obstetricians, pediatricians, and gynecologists, in addition to educational sector providers. To complete our goals, we will: Aim 1. Partner with a well-known not-for-profit theater group in New York City, Houses on the Moon, to commission, implement, test, and disseminate an evidence-based play, coupled with an educational tool kit, for dissemination to national middle and high schools addressing how to prevent and respond to CAN, with the themes of hope and resilience in the forefront. Aim 2. Using CBPR research principles, pilot test an evidence-based instrument in family court settings to assist judges on making custody and visitation schedules in cases involving CAN. This effort stands on the foundation currently underway in partnership with New York State Office of Court Administration. Aim 3. Transform the paradigm for first responders to move from responding to CAN calls for service to preventing it and breaking the intergenerational cycle of violence through partnerships with national and international law enforcement agencies and first responders to amplify as well as create, disseminate, and test educational curriculum. Aim 4. Educate the next generation of pediatric, obstetric, and gynecological professionals and legal professionals regarding CAN prevention through free and credit-bearing continuing education credit programming. Despite decades of our research, the impact of our academic work to improve the lived experience of so many who suffer from CAN has not yet been fully realized. Prior to our first funding cycle, our writing has largely been in peer-reviewed journals, which reach a more restricted audience than that required to have a broad public health impact. TRANSFORM now reaches transdisciplinary professionals, as well as parents and children. With our renewal, we will continue to disseminate our extensive knowledge base to stakeholders not yet reached, thereby more fully addressing social determinants of health related to CAN.